Human NeuromuscularJunction Platform to Evaluate Botulinum Toxin Potency

Project Description:
Botulinum toxin (Botox) has been proven clinically effective in treating symptoms for conditions including vocal
muscle spasticity, strabismus, hyperactive urinary bladder, excessive sweating, and chronic migraine as well as
for numerous cosmetic applications. The measurement of potency for commercially available Botox is primarily
through a mouse lethality bioassay (MLB). There are over 1 million animals sacrificed each year to establish the
potency of clinical dosages of Botox. There are currently few established analytical or in vitro potency testing
available and no pharmacodynamic (PD) or traditional pharmacokinetic (PK) studies have been performed on
commercially marketed Botox. Hickman from UCF published the first dose response curve for BOTOX® in 2018
utilizing their patented neuromuscular junction (NMJ) model and this has been licensed and commercialized by
Hesperos for preclinical disease modeling and toxicity applications. However, it has not been qualified by the
FDA yet. Hesperos is a company founded by Hickman and Dr. Michael Shuler, who is considered the founder of
the body-on-a-chip field. This proposal seeks to submit validation data to the FDA for qualification to establish a
potency assay for Botox and to ensure the capacity to test a significant number of commercial lots on a weekly
basis. The Hickman paper described the construction of a functional neuromuscular junction (NMJ) system
utilizing human cells that enabled the establishment of dose response curves for BOTOX® from Allergan, as well
as curare and bungarotoxin. The system is composed of two chambers that are electrically and fluidically isolated
and connected by small tunnels through which the axons grow and innervate the skeletal muscle and each
chamber can be separately stimulated and dosed (US Patents 8,835,168B2, 9,267,936B2 and 10,935,541). The
first Aim will establish the high throughput NMJ system that will enable 80-100 Botox samples to be evaluated
per week. However, once developed it will be straightforward to build additional systems to scale the testing
capability to over 400 per week, if demand increases. The second Aim will validate the NMJ system with 10
different commercial Botox samples tested using the mouse lethality bioassay (MLB) for dose response to satisfy
the in vivo comparison, and separately for the additional functional parameters. This data will be submitted to
the FDA and then the system will be qualified first with blinded commercial samples from the FDA Toxicological
Branch and then for in person evaluation by FDA staff in similar fashion to qualification of other facilities. This
process, which has been developed in consultation with Drs. Sharma and Fitzpatrick at the FDA and Dr. Tagle
from NCATS, will establish a route by which microphysiological systems available through CROs can be
validated and qualified for all providers, which is confirmed in an email to support this as the test case. This is a
crucial step for commercialization of these MPS models as over half of all preclinical research for pharmaceutical
companies is performed by CROs and a regulatory pathway for MPS in CROs is not currently established.

Public health relevance
Project Narrative The goal of this project is to utilize our human neuromuscular junction (NMJ) platform to replace the mouse lethality bioassay (MLB) currently used to determine potency of commercial batches of Botox. A high throughput platform will be validated and then submitted to the FDA for qualification. We will use nanotechnology and microelectronics in combination with biomedical engineering techniques to build these hybrid 3D biological/non- biological systems.